Enhancing Dendritic Cell Migration to Draining Sentinel Nodes to Improve Immunotherapy Response in HPV negative HNSCC

Project Summary
Human papilloma virus negative (HPV-) head and neck squamous cell carcinoma (HNSCC) is associated with
high mortality and current curative treatment options incur significant morbidity. Despite activity in
recurrent/metastatic settings, PD-1 inhibitors have low response rates of 14-20% in previously untreated, locally
advanced HNSCC when given in the neoadjuvant setting, and recent Phase III trials demonstrate no benefit
when a PD-1 inhibitors are combined with chemotherapy and broad field radiation to primary tumor and draining
lymph node basins. We recently reported that nodal irradiation or surgical removal of draining lymph nodes
completely blocks the anti-tumor activity of PD-1 inhibitors, indicating a key role for tumor draining lymph nodes
in facilitating primary tumor response to immunotherapy. In support of these findings, a Phase I trial of
immunoradiotherapy (IRT) using PD-1 inhibitors combined with lymphatic sparing, stereotactic radiation (SBRT)
demonstrated a remarkable 67% complete pathologic response rate in HNSCC patients. Using orthotopic,
syngeneic murine models of HPV- HNSCC, we found that IRT with sequenced, tumor directed, lymphatic sparing
radiation followed by PD-1 inhibition produces a dramatic, synergistic, and durable tumor response supported
by migration of immune cells to tumor draining sentinel lymph nodes (SLN) and development of clonal T cell
responses in both tumor and SLN. Mechanistically, simple surgical disruption of lymphatic channels connecting
primary tumor and SLN completely blocks response to IRT, and we specifically found that IRT modulates the
phenotype and migration of activated dendritic cells (DCs) from tumor to SLN that are critical to IRT driven anti-
tumor immune responses. Our central hypothesis is that activation and migration of activated DC from
tumor to sentinel lymph node is key to promote anti-tumor immunity and clinical responses to IRT in
HPV- HNSCC patients. We also hypothesize that cross-presenting, activated DC migration can be
enhanced to improve HPV- HNSCC therapeutic response. To explore these hypotheses we will 1) define the
functional state of dendritic cells in tumor and draining sentinel lymph nodes in the context of a Phase II clinical
trial of sequenced neoadjuvant, lymphatic sparing SBRT followed by immunotherapy in HPV- HNSCC patients,
and 2) leverage activated dendritic cell migration to sentinel draining lymph nodes to optimize adaptive immune
responses during immunotherapy and immunoradiotherapy in mouse models of HPV negative HNSCC
Completion of these aims will elucidate the role of specific, activated, migratory dendritic cells in coordinating
anti-tumor immune responses in response to IRT in HPV- HNSCC patients and define dendritic cell immune
signatures in patients treated with IRT in HPV- HSNCC. We will also design novel therapeutic strategies by
leveraging enhanced dendritic cell function and migration to immunologically intact draining lymph nodes in HPV-
HNSCC. This project can inform and guide novel therapeutic approaches based on enhancing activated dendritic
cell migration in HNSCC and other solid tumor types.

Public health relevance
Narrative Cancer immunotherapies has led to major treatment breakthroughs for many cancers, but majority of head and neck cancer patients, particularly those with cancers caused by smoking and alcohol exposure, do not respond to immunotherapies when immunotherapy is part of the initial treatment. We have shown that targeting tumors with stereotactic radiation in combination with immunotherapy while sparing draining lymph nodes enhances anticancer immunity, resulting in dramatic responses in previously untreated patients, and this response is dependent on specific cells (dendritic cells) that recognize tumors and then migrate to specific draining lymph nodes to coordinate immune response against head and neck cancers. The research outlined in this proposal will examine the role of these migrating dendritic cell in immunotherapy response to head and neck cancer and devise new treatment paradigms for treating head and neck cancer that leverage and enhance the power of migratory dendritic cells.